MECHANISM OF GLUCOSE INTOLERANCE IN PREADOLESCENT AND ADOLESCENT CHILDREN

The euglycemic, hyperinsulinemic and hyperglycemic clamp techniques are being employed to determine the effects of age and development stage on insulin sensitivity and insulin secretion in childhood health and disease.